2023 Immunology of Fungal Infections GRC/GRS

PROJECT SUMMARY
This proposal requests partial support for a meeting on the Immunology of Fungal Infections as a part of a
Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) to be held in Galveston, Texas,
January 21-27, 2023. The broad and long-term goal of this conference is to bring together the world's leading
researchers in this rapidly expanding field to foster cross-disciplinary discussions and collaborations. The
meeting is designed to enhance our understanding of anti-fungal immunity with the aim of developing new
insights for controlling these pathogens. The 2023 conference will include a GRS for trainees held immediately
prior to and in conjunction with the GRC. A specific aim of this meeting will be to convene over 40 leading experts
who will present unpublished data and insights within the field of fungal immunology to all attendees. The GRC
program will be structured into 9 sessions that comprehensively cover the various host and fungal factors that
determine innate and adaptive immune responses. Both basic and translational research will be highlighted, with
a major emphasis on cell signaling and stress response of the immune system as well as co-infections. Afternoon
poster sessions will permit all participants to contribute to these topics with the most meritorious abstracts chosen
by the conference Chairs and Vice-Chairs for oral presentations. Every effort will be made to encourage
participation by graduate students and postdoctoral fellows in the GRC. In addition, the GRS will be specifically
aimed at trainees, allowing them to present their research and interact in a relaxing and extra supportive
environment. Every effort will be made to promote gender parity and include racial/ethical minorities and persons
with disabilities. The significance of this application lies in much needed forum provided by the GRC and GRS
to bring together and synergize the members of an international research community working on the immunology
of fungal infections, which remains a highly understudied area. The GRS will have the added value of helping to
train and energize the next generation of researchers in the field. The health relatedness of this application is
that the discussions generated will help define the important questions relating to basic science as well as those
necessary for the development of novel strategies for immunotherapy. With the high levels of mortality and
morbidity associated with these devastating illnesses, the latter are desperately needed.

Public health relevance
PROJECT NARRATIVE Modern medical practices, a variety of surgical interventions, and the AIDS pandemic have led to immune deficiencies and susceptibility to fungal disease in a significant portion of the population. However, our understanding of the pathogenesis of fungal infections and immunity thereto has lagged far behind those of other clinically relevant pathogens. The discussions of the current research at the 2023 Immunology of Fungal Infections Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) will highlight recent advances and define important questions that need to be addressed for the development of new immunotherapeutic strategies for the control of invasive fungal infections.